Mycobacterial Epigenetics: Investigating the impact of DNA methylation on antibiotic tolerance and persistence

PROJECT SUMMARY
Sterilization of tuberculosis (TB) requires lengthy chemotherapy treatment to eradicate persister Mycobacterium
tuberculosis (Mtb) sub-populations. Persister Mtb are unaffected by anti-TB treatment due to their viable but non-
replicating (VBNR) or slowly replicating state in the absence of heritable genetic changes. Persistence is a
reversible phenotype which may be regulated by epigenetic mechanisms. DNA methylation contributes to the
formation of persister bacteria in other bacterial species, but the role for DNA methylation remains unknown in
Mtb persister formation. The objective of this K43 award is to establish the role of DNA methylation in the Mtb
stress response and in the formation of Mtb heterogeneity, which includes the persister sub-population. The
primary mentorship of Drs. Sampson (LMIC primary mentor) and Aldrige (USA primary mentor), both
experienced in mycobacteriology, will provide critical career advancement training. Drs. Sampson and Aldridge
have both contributed to advancing our understanding of Mtb population heterogeneity by developing a
replication reporter plasmid for the identification of Mtb persisters and a microfluidic imaging platform to
investigate cell-to-cell heterogeneity, respectively. This project will build on these advances to address two
specific aims: (1) demonstrate a role for DNA methylation in the Mtb stress response and phenotypic drug
resistance, and (2) demonstrate a role for DNA methylation in Mtb persistence and antibiotic tolerance. This
study will for the first time show that DNA methylation results in changes on a protein level. We will show that
DNA methylation is used by Mtb to respond to environmental stress and promote the formation of a persister
sub-population. Phenotypic drug susceptibility testing and killing assays will assess the impact of DNA
methylation on the ability of Mtb to tolerate antibiotic exposure. Population and single-cell imaging analysis will
assess the impact of DNA methylation on Mtb population heterogeneity, which has previously been shown to
impact treatment efficacy.
At the end of this K43-funded mentored study, the applicant will establish herself as an independently funded TB
research scientist and group leader at Stellenbosch University. Interdisciplinary collaborations established during
this award will lay the foundation for future investigations into the prevention of Mtb persisters for shorter TB
treatment, the identification of biomarkers for diagnosis of persister infections, and prevention of TB recurrence.

Public health relevance
PROJECT NARRATIVE Mycobacterium tuberculosis population heterogeneity, including persister cell formation, can prevent effective therapeutic treatment, resulting in extensive treatment duration and recurrent tuberculosis infection. Triggered persister formation in response to environmental stress may be facilitated through DNA methylation of the M. tuberculosis genome. We aim to demonstrate a role for DNA methylation in the M. tuberculosis stress response and in promoting population heterogeneity, including the formation of a persister sub-population.